Neural Basis of Individual Differences in Fear Extinction

ABSTRACT
While most of the general population, and particularly combat veterans, experience traumatic
events, only a relatively small proportion go on to develop post-traumatic stress disorder (PTSD),
suggesting there are individual differences in susceptibility to the long-term consequences of
traumatic stress. PTSD patients also show impairments in fear extinction, extinction recall, and
safety learning, so extinction learning processes form the basis of exposure-based therapies. We
have observed individual variation in the both freezing and ultrasonic vocalizations (USVs) during
the extinction of cued fear memories in outbred male and female rats, providing a model to study
PTSD-like resistance to fear extinction. Veterans with PTSD show a very high prevalence of sleep
disturbances, and evidence suggests that sleep disturbances predict the development, severity
and treatment responses in PTSD. This proposal examines the role of sleep dysregulation in
mediating individual differences in extinguishing fear memories and the neurobiological
mechanisms underlying these interactions. Cholinergic inputs from the basal forebrain (BF)
provide strong inputs to the prefrontal (PFC)-amygdalar circuit which is important for fear
extinction, and our results from prior funding suggest that individual differences in cued fear
extinction are related to differences in cholinergic neurotransmission and function. Our
overarching hypothesis is that the individual differences in fear extinction emerge from alterations
in sleep after traumatic stress. Based on the known role of the cholinergic and orexinergic
systems, as well as the kynurenine pathway (KP), in modulating both sleep and fear extinction,
we propose that sleep disruptions and resistance to fear extinction are mediated by innate
variations in the modulation of the cholinergic system by orexin and the kynurenine pathway. We
will investigate the interactions between sleep dysregulation and fear extinction in both males and
females using polysomnography recordings of EEG and EMG signals using telemetry during our
fear learning and extinction paradigm. Since we have seen sex-dependent differences in USVs
during fear learning and extinction, proposed studies examine both freezing and USVs in the 22
kHz and 50 kHz range in our behavioral analyses. Aim 1 will test the hypothesis that either innate
disruptions in sleep and/or sleep deprivation are associated with resistance to fear extinction. This
Aim investigates the ability of Sleep Deprivation during the fear learning and extinction paradigm
to increase the kynurenine metabolite kynurenic acid (KYNA) in the brain and induce disruptions
in sleep leading to extinction resistance, and these effects may be due to activation of the
orexin/hypocretin system. In Aim 2 we test if targeted inhibition of kynurenine aminotransferase II
(KAT II), the enzyme responsible for KYNA formation, can alleviate sleep disturbances and
enhance fear extinction recall. The efficacy of KATII inhibition to improve sleep and enhance fear
extinction will be compared with a dual orexin receptor antagonist (DORA) suvorexant that is also
known to improve sleep. Finally, Aim 3 will interrogate the mechanistic role of BF-PFC cholinergic
circuit in fear extinction using chemogenetic approaches, and assess the impact of KYNA and
orexin on acetylcholine release in this circuit during fear extinction. Together these studies would
provide evidence for novel therapeutic targets that might not only help treat sleep disturbances in
Veterans with PTSD but elucidate the role of sleep dysregulation in the development of symptoms
associated with PTSD, and potentially improve the efficacy of exposure therapies.

Public health relevance
Relevance to VA: The proposed studies use innovative technologies and a translational animal model to help establish evidence-based medical practices for treatment of PTSD in men and women veterans. The VA’s ORD supports a strong program of research toward understanding, treating, and preventing the neurobiological responses to a traumatic event during combat duty. While most combat veterans experience traumatic events only a relatively small proportion go on to develop PTSD, suggesting some individuals are more susceptible to such stress. The proposed studies use an animal model to better understand the neurobiological mechanisms underlying individual differences inability to extinguish fear memories during repeated exposure to trauma-related cues, even in a safe environment. We focus on the role of sleep disruptions in the development of PTSD-like responses and use this model to test pharmacologic approaches that could augment the effectiveness of treatment approaches and improve sleep in veterans with PTSD.